Development of a Next-generation Rapid Phenotypic Assay for Drug-Resistant M. tuberculosis

PROJECT SUMMARY
The long turnaround time and need for specialised laboratories for conventional culture-based Mycobacterium
tuberculosis drug-susceptibility testing (DST) regularly commits patients with drug-resistant tuberculosis (DR-
TB) to months of potentially ineffective treatments. Current commercial molecular tuberculosis (TB) tests can
rapidly identify DR-TB but are limited to testing resistance to a small number of drugs, excluding any new drugs.
In theory, next-generation sequencing (NGS) could comprehensively identify resistance profiles, but is currently
prohibitively expensive for routine use in high-burden, low-resource settings, and knowledge on drug-resistance
mutations is still incomplete. To address this barrier, a fluorescence-based phenotypic assay will be developed
to identify with high specificity resistance to drugs contained in the so-called “BPaLM” regimen, in clinical
specimens. The overall goal of the current K43 application is to advance a novel phenotypic solution to transform
the clinical management of DR-TB in high burden settings. The objectives of the K43 proposal are to 1) provide
critical career advancing training and 2) advance and evaluate a rapid phenotypic workflow requiring minimal
hands-on time within a high throughput TB laboratory. The sample collections and technical staff from an existing
NIH-funded R01 (R01AI153213, PI: John Metcalfe, US primary mentor on this proposal) cluster randomized
controlled trial evaluating the programmatic outcomes associated with benchtop NGS sequencing (the “TS Eliot
study”) will be leveraged. Dr. Rob Warren, Distinguished Professor at Stellenbosch University and the Unit
Director of the South African Medical Research Council Centre for Tuberculosis Research will serve as the LMIC
mentor. Both Dr. Metcalfe and Dr. Warren have vast experience in molecular epidemiology, drug-resistant TB,
and development of diagnostic tests. The project will have the following specific aims: 1) Advance a fluorescence-
based assay as a rapid, high-throughput pDST, and 2) Perform preliminary diagnostic accuracy evaluation of
the assay to detect phenotypic resistance directly in clinical TB specimens. In this study rapid, comprehensive
DST methods will be established, which will continue to inform molecular assays for testing of new and
repurposed drugs. At the end of this K43-funded mentored program, the applicant is expected to be able to lead
a research project independently in the low-resource setting of South Africa. In future research projects based
on the preliminary data generated in the current project, she will be able to answer key questions related to drug-
resistant TB.

Public health relevance
PROJECT NARRATIVE Drug-resistant tuberculosis is a major health concern which requires updated and improved diagnostic tools to inform individualised and standardised treatment protocols. There is a particular need for tests that can provide rapid results in high-throughput laboratories. This project will provide such tools in the form of microvolume, arrayed tests based on growth detection by means of standard methods and fluorescent probes.